URBAN HEALTH NETWORK

DESCRIPTION: The purpose of this project is to expand Public Health Television's use of its culturally-specific production process pioneered in Phase I by developing and evaluating additional cancer-related video programming targeted to urban, low-income African Americans and the health care professionals who serve them. The project teams television professionals, social scientists, cancer specialists, and African-American residents of Cleveland's public housing estates. The objectives are: 1) to develop and evaluate the effectiveness of an Urban Cancer Television Campaign; 2) to develop and evaluate the feasibility of introducing a clinical trials video into an oncology practice and explore the video's effectiveness in encouraging African Americans to enroll in clinical trials; and, 3) to develop a cultural competency training video and explore its impart on an oncology staffs attitudes and perceptions of cultural issues, as they relate to treating African American patients. These Phase II efforts will lay the foundation to achieve PHTV's ultimate Phase III goal: to build a library of compelling, culturally-specific videos to market to the broadcast media and the health care industry, as well as distribute through conventional sales and the Internet.